Collaborative Study on the Genetics of Alcoholism (COGA)

COGA Supplement ? Project Summary The Collaborative Study on the Genetics of Alcoholism (COGA) is a tightly integrated and interdisciplinary project, whose overarching goals are to understand the contributions and interactions of genetic, neurobiological, and environmental factors on risk and resilience over the developmental course of AUD. COGA is a family-based study with rich data on an ethnically diverse group of 12,145 family members. More than 650 scientific papers have been written using the COGA data, yet there is a clear need to communicate the vast array of findings on genetic contributions to AUD with the public. Relevant to this mission, as part of the renewal application, COGA incorporated a new Translational Director into its administrative structure to spearhead a translational agenda for COGA, in collaboration with COGA investigators. We note that the grant renewal did not include any funds earmarked for translational efforts — only a commitment to evaluating areas where COGA could make unique contributions. The first area we have identified where there is a gap in knowledge, and where COGA is uniquely positioned to make a significant contribution, is via the development of web-based resources for the public. In this administrative supplement, we request funds to build out these resources to meaningfully contribute to the translation of research findings to the public. The funds would specifically be used to (1) create engaging web- based content, (2) conduct pilot testing to ensure the developed material is resonating with our target audience, and (3) optimize our reach and measure impact.

Public health relevance
Alcohol Use Disorders (AUD) are a major social and health problem, the prominence of which continues to grow in mid-life and later life. The Collaborative Study on the Genetics of Alcoholism (COGA) is a tightly integrated and interdisciplinary project, whose overarching goals are to understand the contributions and interactions of genetic, neurobiological, and socio-environmental factors on risk and resilience over the developmental course of AUD, including relapse and recovery. The three COGA projects (Genomics, Brain Function, Lifespan), supported by three cores (Administrative, Data Management and NIAAA/COGA Sharing Repository) aim to address the public health challenge of AUD by integrating findings across multiple domains of research. By crafting a more integrated view of the architecture of AUD, COGA is well poised to inform future efforts aimed at curbing the deleterious consequences of AUD on persons and the population.